Decoding the neural mechanism underlying variable action selection in Drosophila.

Project Summary/Abstract
There is a fundamental gap in our understanding of how complex, multi-action, behavioral variability is
generated by neural circuits in the brain. Understanding this process is crucial to understanding how many
neurological diseases cause restricted and inappropriate selection of actions. The goal of this proposal is to
understand how populations of neurons control the behavioral variability in action selection for complex
behaviors. We will utilize the fruit fly to investigate this question because despite having a much simpler brain
than humans, the fruit fly performs complex behaviors with high variability. We have found that activating just
24 neurons in the fruit fly brain causes variable expression of four distinct aggressive actions: stopping, wing
elevation, leg extension, and lunging. The relative simplicity of this system is ideal for pin-pointing the
contribution of different sources of variability: cell-autonomous stochasticity in action potential generation,
variability at a network-level or variability in muscles or other neurons affected by the 24 neurons. To test these
sources for variability, the project will consist of three main aims. The first is to determine whether the actions
are discrete states of behavior or lie within a continuum by using advances in machine learning and
neuroethology to automate the identification of the aggressive behavioral actions and the transitions between
these actions. The second is to test the hypothesis that each action is caused by neurons with similar
neuroanatomical connections using neuroimaging, genetic manipulation, and controlled behavioral
experiments. The third is to use functional imaging, in vivo electrophysiological recordings, and computational
modeling to determine the neural basis for the variability of behavior. By combining theory, experimentation,
and modeling, we will be able to provide a systems level explanation of the logic behind why animals perform
different actions despite consistent levels of neuronal activation.

Public health relevance
Project Narrative The ability to flexibly and appropriately perform action selection is altered in many neurological and psychiatric diseases. However, the mechanism behind the variability in action selection while performing complex behaviors is not understood. By quantifying, modeling, and decoding the neural logic behind the variability in action selection of a fruit fly, we aim to build new theories about how our own brain works and provide insight into better treatment of diseases affecting proper execution of behaviors.